The impact of antinuclear antibodies on alloimmune responses to renal transplants

Abstract
Autoantibodies (autoAb) are recognized as an important factor influencing the survival of transplanted solid
organs. The vast majority of autoAbs implicated in poor transplant outcome target the components of
extracellular matrix, cell surface and cytosolic proteins and are associated with chronic rejection months and
years after transplantation. While anti-nuclear autoAb (ANA) are a hallmark feature of several autoimmune
diseases, the data on the impact of ANA in transplant recipients is limited. Clinical studies in cardiac and renal
transplantation revealed associations between high ANA levels and increased alloimmunity, development of
antibody-mediated rejection, inferior graft function and increased mortality. Our published and preliminary data
in a mouse kidney transplantation model demonstrate that ANA develop early after transplantation and that
autoAb against representative nuclear antigen DNA Topoisomerase I enhance activation of donor-reactive T cells
and lead to acute graft rejection of renal allografts. Thus, the experimental and clinical studies strongly suggest
that autoimmunity to nuclear antigens can exacerbate alloimmune responses in renal transplant recipients.
However, the mechanisms underlying the effects of ANA on MHC-reactive immune responses and graft injury
remain poorly understood. The goal of the proposed studies is to investigate the mechanisms by which ANA
promote activation and effector functions of alloreactive T cells and to test strategies for preventing pathogenic
effects of ANA in renal allograft recipients.
We hypothesize that pre-existing ANA bind the fragments of dying graft cells and enhance T cell activation by:
1) increasing posttransplant ischemia/reperfusion injury (IRI) through FcγR- and complement-mediated
neutrophil recruitment and activation to exacerbate the release of donor alloantigens; and, 2) facilitating recipient
DC activation and donor antigen presentation via FcγR/TLR/IFN axis. This results in increased priming and
effector functions of alloreactive T cells and anti-MHC DSA generation leading to graft injury and rejection.
Aim 1. To investigate the effects of ANA on donor alloantigen presentation to donor-reactive T cells
following renal transplantation.
Aim 2. To test whether ANA impacts donor antigen release and subsequent alloreactive T cell responses
by increasing the magnitude of ischemia/reperfusion injury.
The findings of the proposed studies may improve clinical prediction of poor transplant outcomes, guide
therapeutic interventions in high-risk individuals, and identify new cellular and molecular targets to diminish the
pathogenic impact of autoAbs in transplant recipients.

Public health relevance
Project Narrative Antibodies against self-antigens develop after organ transplantation and are associated with increased graft tissue injury and rejection. The proposed studies will investigate how autoantibodies enhance activation and functions of donor-reactive T cells, and test strategies for preventing pathogenic effects of autoantibodies in renal allograft recipients. The findings may improve prediction of poor transplant outcomes, guide therapeutic interventions in high-risk individuals, and identify new cellular and molecular targets to diminish the pathogenic impact of autoantibodies in clinical transplantation.